REPOSITORY SERVICES FOR WOMENS INTERAGENCY HIV STUDY (WIHS) STAR SPECIAL TREATMENT AND RESEARCH (STAR)

The Women’s Interagency HIV Study (WIHS) is a large, comprehensive prospective cohort study designed to investigate the progression of HIV disease in women. The WIHS began in 1993 in response to growing concern about the impact of HIV on women. The core study visit includes a detailed and structured interview, physical and gynecologic examinations, and laboratory testing. After more than 20 years, the WIHS continues to investigate questions at the forefront of HIV research, spanning topics such as women’s reproductive health, clinical outcomes (for example, cardiovascular disease, diabetes, and others), and the effectiveness of antiretroviral therapy.
An expansion of the long running ill be collecting specimens that require repository services, including plasma, viable cells (PBMC), serum, urine, vaginal swabs, oral swabs, rectal swabs, hair samples, saliva, and oral plaques.